Administrative Core

Project Summary – Administrative Core
The Administration Core provides an important facilitative resource to Weill Cornell Medicine's Autoimmunity
Center of Excellence (ACE) entitled, `Immune Cells and Secretory Pathways Leading to Human Systemic
Autoimmunity'. The proposed Center is comprised of a highly integrated multidisciplinary team composed of
scientists, physician scientists, computational biologists and other technical staff and involves a Principal
Project, a Collaborative Research Project, a Pilot Project and two Cores (Administrative and ACE Funds
Management). Thus, there is considerable need to organize various activities and provide support in order to
facilitate a cohesive, efficient and productive ACE team at WCM. The Administrative Core will have a Director,
an Administrative Director and a Project Manager and will be responsible for this coordination and assistance.
Objectives of this Core are to: 1) Promote and facilitate interactions and communication among all Center
investigators, projects, cores and collaborators, especially with other ACE sites; 2) Prioritize, allocate, and
manage resources – including budgets and personnel; 3) Facilitate sample acquisition and retrieval of clinical
data from local clinics and other collaborators, including ACE sites; 4) Facilitate data sharing and provide
access to data management infrastructure within the Center at WCM and outside, especially with other ACE
sites; 5) Oversee issues related to intellectual property and regulatory issues related to research using
human subjects; and 6) Organize meetings, meeting reports and annual NIH reports.